Diabetes Research Center

PROJECT SUMMARY: Center Overview
The Washington University (WashU) School of Medicine (WUSM) Diabetes Research Center (DRC)
has a goal of decreasing human suffering by pursuing the scientific theme of interdisciplinary cooperation
across the translational research spectrum to develop new therapies and improve the health of
Americans with or at risk for diabetes, its complications, and related endocrine and metabolic
disorders. The DRC is needed to catalyze innovative thinking that includes diabetes as a biological variable
by investigators in the research base with complementary skills. Consisting of 126 members supported by
>$57 million in direct costs, the exceptional research base has expertise spanning the translational spectrum
including groups that focus on Metabolic Regulation, Islet Biology and Immunology, Prevention and Control,
and Complications. Their creativity is facilitated by the evolving services of six biomedical research Cores: Cell
and Tissue Imaging Core, Diabetes Models Phenotyping Core, Metabolic Tissue Function Core, Mass
Spectrometry Core (which has been substantially expanded), Translational Diagnostics Core, Diabetes
and Infection Core (which is new). Novel approaches are nurtured by the WashU Pilot and Feasibility
Program, which continues to launch the careers of high impact diabetes scientists, as well as the expanded
Pilot and Feasibility Program, which fosters interdisciplinary research at the Universities of Kentucky, Utah, and
Wisconsin. Dynamic Enrichment Program activities include fluid interactions with diabetes related T32
programs at WashU, the NIDDK Medical Student Research Program, and other NIDDK supported centers to
raise awareness and interest in diabetes research. Now in its 45th year, the DRC at Washington University is
positioned to continue translating new findings into strategies that improve the health of people with diabetes.

Public health relevance
NARRATIVE: Center Overview Research addressing diabetes, related conditions, and their complications is relevant to public health because these disorders cause enormous suffering and death in addition to burdening the American health care system with the highest health and economic costs among chronic diseases. Through sophisticated Biomedical Research Core services, innovative Pilot and Feasibility projects, and engaging Enrichment activities, the Washington University Diabetes Research Center (DRC) conducts research that is an important component of efforts to treat, cure, and prevent diabetes and related endocrine and metabolic disorders.